The Impact of Treatment Adherence on A Clinical Biomarker in Pediatric Acute Lymp

DESCRIPTION (provided by applicant): The candidate, Ms. Jennifer Rohan, is a second-year graduate student in the Clinical Health Psychology doctoral program with an emphasis in Pediatric Psychology at the University of Cincinnati. She is working under the mentorship of Dr. Dennis Drotar, Professor and Director of the Center for Treatment Adherence at Cincinnati Children's Hospital Medical Center. [The sponsor and co-sponsor mentorship team was chosen based on their content expertise in key areas related to the application as well as Ms. Rohans collaboration with Drs. Vinks1and Rausch on various research projects. Drs. Perentesis (Oncologist/Director of Hematology-Oncology at CCHMC) and Huang (Biostatistician) were chosen as consultants/mentors for Ms. Rohan to gain specialized training in pediatric cancer and ALL as well as advanced data analytic methods respectively]. The proposed training plan includes opportunities for training in pediatric cancer, research ethics, advanced statistical techniques, pharmacological and research methods related to treatment adherence, and [comprehensive clinical management of pediatric adherence in a range of chronic conditions]. The proposed training proposal will facilitate dissertation analyses that will examine [predictors of] treatment adherence, [including] treatment status, and psychosocial factors. These opportunities will facilitate Ms. Rohan's professional development as a [pediatric psychology] researcher, and facilitate her career potential [to conduct research in pediatric cancer as well as other chronic illness populations]. Ms. Rohan's long-term career goal is to obtain a research-focused tenure-track faculty position in a pediatric medical center and/or university academic setting and conduct research investigating treatment adherence and self-management in the context of pediatric chronic illness, specifically pediatric cancer. [It should be noted that the proposed measurement plan and data analytic strategy being used in the current study has broad applicability and generalizability to other chronic conditions. As1evidenced1by1Ms1Rohans1training1to1date¿1she1 is interested in a broad range of chronic conditions and plans to work with a number of disease populations in her career]. The proposed NRSA predoctoral fellowship (F31) will investigate treatment adherence to a daily chemotherapy medication in a sample of children and adolescents (N = 138) ages 7-18 years diagnosed with acute lymphoblastic leukemia. The proposed project is a secondary data analysis using data collected from an ongoing parent study currently funded by the National Cancer Institute (PI: Drotar; R01 CA119162). It should be noted that the proposed research presented in this NRSA was not a part of the primary or secondary aims of the larger parent study. The proposed study involves a new data analytic strategy that would not have otherwise been conducted if not1for1Ms1Rohans 1interest1in1combining two objective methods of treatment adherence (behavioral/pharmacological) to predict a clinical outcome (absolute neutrophil count: ANC). The parent study sample is ideal for the proposed data analytic strategies that require samples of 100 or more participants and would not otherwise be available using one site.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed NRSA predoctoral fellowship (F31) will provide Ms. Rohan with the opportunity to investigate two objective measures of medication adherence in pediatric cancer to determine the role adherence has on a clinical biomarker (absolute neutrophil count). This will advance research and clinical practice for determining how adherence to a prescribed daily medication affects clinical biomarkers. The fellowship training plan will also provide Ms. Rohan with ample opportunities to enhance her skills development [in conducting research with chronic illness populations, conducting advanced statistical and data analytic methods, and preparation] and training for a research career in pediatric chronic illness, treatment adherence, [and randomized controlled trials]. [The proposed research plan is different from the currently funded parent R01 in that it proposes a data analytic strategy and method that would not have otherwise been conducted as part of the parent proposal. This research plan was independently proposed by Ms. Rohan based on its potential broad applicability to the measurement of treatment adherence in other chronic illness populations.] __SpecificAimsTextDelimiter__ B2) Specific Aims Treatment nonadherence is a common problem in the management of pediatric chronic illness that has the potential for extraordinary negative consequences on health [1]. Pediatric cancer is no exception. Previous research has suggested that adherence to prescribed treatment regimens during the maintenance phase of treatment is difficult for children and adolescents diagnosed with acute lymphoblastic leukemia (ALL), and nonadherence to treatment regimens, specifically oral medications, is prevalent [2]. The maintenance phase of therapy for ALL is considered vital for survival and long-term success in pediatric ALL [2-4]. Nonadherence to prescribed medication may not be readily detected by clinicians because patients and parents are unlikely to admit to missed doses [3, 5, 6]. However, nonadherence to maintenance phase medications in pediatric cancer such as 6-mercaptopurine (6MP) can be identified through objective measures of treatment adherence (e.g., behavioral and pharmacological measures), which provide an advance over routinely used subjective methods (e.g., self-report, physician-report). Previous research in pediatric ALL has noted the importance of using these measures together to describe 6MP medication adherence as opposed to separately because of their combined utility [6-8], however, this has not been previously done in pediatric ALL. Pharmacological measures (e.g., 6MP metabolite concentration levels) allow clinicians to determine if the drug was ingested prior to a blood draw by providing the level of drug metabolites found in the body, and behavioral measures (e.g., electronic monitoring of 6MP) reveal the pattern of drug taking behavior. This provides multidimensional, objective adherence data regarding the history of medication taking, which could provide insight regarding clinical outcomes/biomarkers. Previous research investigating oral medication adherence in pediatric ALL has generally involved small samples, has not used objective measures consistently, and has not involved prospective study of adherence patterns over time. The proposed study will meet these needs. Pediatric cancer is an exemplar chronic condition in which to utilize both behavioral (e.g., electronic monitoring) and pharmacological (e.g., metabolites of 6MP) measures to examine 6MP adherence in children and adolescents to provide more valid prediction of health outcomes/biomarkers (e.g., absolute neutrophil count: ANC). This research proposal will investigate the combined utility of using these two objective measures of oral 6MP medication adherence to predict a biomarker (e.g., ANC) over [15 months] in a multisite cohort of children and adolescents ages 7-18 years (N = 138) with ALL. The proposed research will have a significant impact on science by determining the utility of combining these two measures of oral medication adherence in pediatric ALL to describe longitudinal 6MP medication adherence patterns and to determine if behavioral and pharmacological measures of 6MP adherence can more validly predict a biomarker compared to single measures of treatment adherence. The proposed data analytic strategy will advance science by providing objective data on the patterns of adherence to 6MP medication over [15 months] based on 6MP electronic monitoring and 6MP metabolite concentration levels in a relatively large sample of children and adolescents with ALL during the maintenance phase of treatment. We anticipate that the eventual application of these objective methods will facilitate more effective clinical management of ALL by providing more targeted clinical management and adherence promotion interventions. There are three aims of the proposed study: Aim 1: Describe 6MP adherence patterns over [15 months] for a sample of children and adolescents diagnosed with pediatric cancer based on electronic monitoring and metabolite concentration data. 6MP adherence patterns will be examined separately for electronic monitoring and metabolite concentration data. It is hypothesized that the overall rate of 6MP adherence as measured by electronic monitoring will decrease over [15 months] for the sample as a whole. However, we also anticipate that there will be individual differences in patterns of 6MP adherence. 6MP is metabolized into two metabolites (TGN and MMP). Based on previous research that investigated 6MP metabolite concentration levels at one time point [8, 9], it is hypothesized that there will be three unique group trajectories of individuals with similar metabolite profiles over [15 months]: one group that demonstrates nonadherence (low levels of both TGN/MMP), and two groups that demonstrate a negative correlation between the two metabolites, [which reflects adherence to 6MP [26]]. Aim 2: Document the relationship between 6MP adherence measured by behavioral (e.g., electronic monitoring) and pharmacological (e.g., 6MP metabolite concentrations) over [15 months]. It is hypothesized there will be a moderate relationship between 6MP metabolites (TGN and MMP) and behavioral adherence across [15 months]. It is also hypothesized that there will be a significant difference in behavioral adherence patterns between the 6MP metabolite group-based trajectories. Those individuals who are in the nonadherent group will have the lowest behavioral adherence rates compared to the other group trajectories. Aim 3: Determine the relationship between behavioral and pharmacological measures of 6MP adherence to a biomarker (absolute neutrophil count: ANC). It is hypothesized that consistently lower 6MP adherence rates from baseline to 15 months based on electronic monitoring and group trajectory profiles describing metabolite concentrations of 6MP will predict worse absolute neutrophil counts (ANC) over time.